Magnetic Resonance Imaging of Outbred Rats with Variable Vulnerability to Compulsive Alcohol Use

PROJECT SUMMARY/ABSTRACT
Advancements in neuroscience, including magnetic resonance imaging (MRI), have signiﬁcantly improved our
understanding of alcohol use disorder (AUD) and brain function, yet due to the heterogeneity in the disorder
and complexity of the brain, controlled comprehensive approaches in diverse populations are a necessity to
characterize individual variability. Here, longitudinal multi-parametric MRI will be employed to assess brain
features associated with AUD in a large cohort (N=100, 50% female) of genetically diverse (heterogeneous
stock) rats sourced from the NIAAA-funded Rat Alcohol Biobank (1R01AA030048, 5R01AA029688), which
provides rats with fully characterized genome and addiction-like behaviors, going through a state-of-the-art
pipeline with escalation of alcohol intake following intermittent exposure to alcohol vapor.
Leveraging features from structural, diffusion, and functional MRI, our investigation seeks to capture the
individual differences in the brain, at baseline before alcohol exposure (Aim 1: pre-existing), and following the
alcohol paradigm during acute withdrawal (24 h) and protracted abstinence (5 weeks) (Aim 2: alcohol-induced),
within the same rats that show vulnerability or resilience to developing alcohol addiction-like behaviors. We
hypothesize that there will be an interaction between the results from both aims. The brain of a subset of
animals will be harvested after longitudinal MRI for complementary single-cell whole-brain imaging (SCWBI),
using light sheet microscopy following brain clearing and immunohistochemistry co-labeling of neurons (NeuN),
activation (Fos), and stress signaling (CRF), to provide insights into the cellular underpinnings of the observed
MRI brain features associated with AUD (Aim 3). We hypothesize that neuronal loss and activation of the
stress circuit will correlate with the alcohol addiction-like behaviors, some MRI brain features, and underlying
genomic differences.
Through this collaborative endeavor with the Rat Alcohol Biobank, we anticipate the generation of a large,
diverse, and high-quality dataset that will be made publicly available and will contribute signiﬁcantly to our
understanding of the diverse impact of alcohol on the brain and individual differences in vulnerability to AUD.
This Katz proposal provides a unique opportunity to disentangle pre-existing differences from those that are a
consequence of exposure to alcohol using a, for the PI new, clinically relevant approach, which will
complement her current preclinical work with SCWBI and simplify the translation of the ﬁndings for human
applications. Ultimately, this research seeks to pave the way for improved prevention and personalized
treatment strategies, thereby reducing illness and disability associated with AUD.

Public health relevance
PROJECT NARRATIVE This research seeks to unravel the intricacies of brain differences in relation to individual vulnerability to alcohol use disorder by longitudinally imaging the brains of a rat model that mimics the variability of the human population and is characterized for addiction-like behaviors, before and after chronic exposure to alcohol. By integrating preclinical and clinically relevant approaches, ultimately, obtained insights could be translated to lead to better, more personalized strategies for preventing and treating alcohol use disorder and reducing the impact of alcohol-related problems on public health.